ACTG 823--RIFABUTIN AND ETHAMBUTOL ON PHARMACOKINETICS OF CLARITHROMYCIN

To study the pharmacokinetic interactions of Rifabutin and Ethambutol on Clarithromycin and of Ritonavir or Indinavir on Rifabutin and Clarithromycin in the treatment of MAC disease.